Gynecologic cancer care: Improving clinical trial enrollment through molecular matching with targeted therapies and improving access to care and research

Gynecologic Cancer remains an underfunded area of research with funding to lethality scores significantly lower than other cancer sites. Endometrial cancer, the most common gynecologic cancer, is one of the few cancers that has seen an increase in incidence and mortality over the recent years.. High risk and rare subtypes of uterine cancers have distinct molecular profiles. Recent research has identified several molecular subtypes that can be targeted with novel agents. Molecularly driven trials are critical to the progress of personalized medicine to improve survival and limit exposure to ineffective therapy and associated toxicities. Unfortunately, these highly specialized clinical trials are at risk of failure due to slow accrual due to the rarity of certain cancer subtypes. As the national PI for NCI/NRG-GY020 (vaginal brachytherapy +/- immunotherapy for early stage high risk mismatch repair deficient endometrial cancer, which is a subset of endometrial cancer patients who are highly sensitive to immunotherapy) Dr. Backes is well aware of the opportunities and challenges associated with molecularly driven clinical trials. NCI support through the R50 mechanism will allow Dr. Backes to increase her efforts to improve enrollment to clinical trials for all populations, both at her institution and nationally. First, leveraging the resources of the Ohio State University Comprehensive Cancer Center (OSUCCC), Dr. Backes will develop a comprehensive system for molecular matching to simplify and streamline the identification of patients for trials and specialized trials for patients, which will increase accrual. Collaborative cross-disciplinary efforts are especially important with the increasing complexity of molecularly driven clinical trials, such as NCI ComboMatch and iMatch, and also to improve the outcomes of patients with rare tumor mutations. Secondly, Dr. Backes will collaborate with Dr. Elektra Paskett to include gynecologic oncology on a recently opened study that aims to connect patients to clinical trials. Dr. Backes and Dr. Ashley Felix (PhD, Epidemiology) will focus on assessing barriers and implement strategies to improve access to care and clinical trials in gynecologic oncology locally and nationally. Finally, the opportunities afforded by this award will allow Dr. Backes to increase her time to design and support the development of paradigm shifting clinical trials, and mentor junior investigators in this process, through her national roles as the NRG Oncology Co-Chair for Developmental Therapeutics, member of the Uterine Corpus Committee, New Investigator Committee, NCI Uterine Taskforce, national PI for NRG-GY020 and other trials under development, and in additional local roles as the Disease Specific Research Group Leader, NRG Oncology site PI for Gynecologic Oncology and Fellowship Director.

Public health relevance
Project Narrative Dr. Floor Backes is exceptionally passionate about improving outcomes of all patients through participation in clinical trials with equal access to care and research. This award would support Dr. Backes to work within NRG Oncology continue to design, develop, and support novel paradigm shifting clinical trials as principle investigator, mentor, Co-Chair of the NRG Oncology Developmental Therapeutics (DT) committee, member of the Uterine Corpus Committee, and NCI Uterine Taskforce. Local institutional goals are to support the Ohio State University and James Comprehensive Cancer Center to develop a comprehensive system for multidisciplinary collaboration and molecular matching increase enrollment to NCTN trials and especially to disease agnostic molecular driven trials, streamline trial implementation and to increase the referral and accrual of racial/ethnic minorities to NCI’s National Clinical Trials Network (NCTN) prevention/control and treatment trials.